Research Supplement to Promote Diversity in Health-Related Research-Functions of gustatory afferent neuron types.

ABSTRACT
This application is for a Diversity Supplement to fund an enthusiastic young Hispanic female neuroscience
graduate from the University of Florida, Isabella Fleites. Isabella wants to strengthen her research
experience in sensory neurobiology and build a solid foundation for future graduate studies so that she can
build her career in neuroscience. Isabella feels that although her science background is strong, she needs
experience in molecular and cellular approaches to prepare her for competitive graduate programs.
My laboratory is ideally suited to helping Isabella succeed in her goals. She will learn key experimental skills
to supplement her background in the sciences. Specifically, my colleagues and I will train her to conduct in
vivo confocal Ca2+ imaging to record activity in gustatory receptor cells and in sensory ganglion neurons.
This involves learning delicate surgical procedures on genetically engineered (transgenic) mice, operating
computer-controlled sensory stimulation and confocal video image capture, and carrying out sophisticated
data analyses using advanced software apps. In addition to these technical skills, Isabella will learn how to
interpret complex data and to develop new experimental approaches to existing problems. By daily
interactions with others in my laboratory and in the laboratory of my collaborator, Dr. Nirupa Chaudhari, an
eminent molecular biologist, as well as via weekly joint laboratory meetings, Isabella will learn how to
interact as a peer with other researchers, how to share ideas, how to solve problems, and how to
communicate science. I have considerable experience and established success mentoring young scientists.
Dr. Chaudhari and our lab staff are also eager to assist Isabella.
The goals of this Diversity Supplement are to:
· introduce Isabella to new research skillsꟷin vivo confocal Ca2+ imagingꟷto add to her formal
neuroscience research training and to carry out an semi-independent project that is within the scope
of ongoing studies in the parent grant, R01 DC018733, “Functions of gustatory afferent neuron types”,
MPI's S Roper and N Chaudhari.
· mentor Isabella in experimental design, analysis, and data interpretation. In addition to my own effort,
this will be aided by informal daily interactions among members of two active research laboratories
(Drs. Roper, Chaudhari) as well as via weekly joint laboratory meetings, periodic departmental
seminars, and presenting findings at an annual campus neuroscience fair as well as a national
conference (AChemS, SFN, or both).
· allow Isabella to attend workshops and short courses in statistics, computation and molecular
neuroscience provided by the university to extend her skill and knowledge set.
· provide Isabella with an intense training background and portfolio of publication(s) to enable her to
compete for a PhD program at a ranking national institution, with the ultimate goal of developing her
own independent career as a neuroscientist.

Public health relevance
NARRATIVE This proposal for a Research Supplement to Promote Diversity (parent MPI grant, R01 DC018733, “Functions of gustatory afferent neuron types”, co-PI's S Roper and N Chaudhari) will fund the training of an enthusiastic, talented young Hispanic female neuroscience graduate, Ms. Isabella Fleites. Isabella is an honors graduate in Behavioral and Cognitive Neuroscience at the University of Florida, a researcher in the McKnight Brain Institute at the University of Florida, and an award-winning participant in the nationally competitive SURF (Summer Undergraduate Research Fellowship) program at the University of Miami. SURF aims, in large part, to promote diversity in the scientific community. Isabella is keen to continue her training in sensory neuroscience and work on questions of sensory coding in my laboratory. She will be mentored by several collaborators as well as myself and will conduct an independent study closely related to ongoing studies in the parent grant. Isabella will present her findings at local and national meetings and will aim for at least one publication to strengthen her ability to compete for enrollment in a ranking national PhD program en route for her goal of a career in scientific research.